Genes and signals controlling mammalian hematopoiesis.

Our research is focused in four main areas: 1) characterization of the role of T cell antigen receptor (TCR) signals in T cell development. 2) identification and analysis of signal 'tuning' molecules that function downstream of the TCR that augment or inhibit TCR signaling. The aim of these studies is to understand how these molecules participate in TCR mediated signaling and to determine what roles they and the signaling pathways they regulate play in T cell maturation and T cell activation. These molecules may represent targets for immunotherapy in humans. 3) Identification and characterization of new molecules that have important roles in T cell development. 4) Studies of the genes controlling the generation, maintenance and differentiation of Hematopoietic Stem Cells (HSCs). Examining the role of T cell antigen receptor (TCR) signaling in thymocyte development. Signal transduction sequences (termed Immunoreceptor Tyrosine-based Activation Motifs; ITAMs) are contained within four different subunits of the multimeric TCR complex (zeta, CD3-gamma, -delta, -epsilon). Di-tyrosine residues within ITAMs are phosphorylated upon TCR engagement and function to recruit signaling molecules, such as protein tyrosine kinases, to the TCR complex, thereby initiating the T cell activation cascade. To determine if TCR signal transducing subunits perform distinct or analogous functions in development, we previously generated zeta deficient and CD3-epsilon deficient mice by gene targeting, genetically reconstituted these mice with transgenes encoding wild-type or signaling-deficient (ITAM-mutant) forms of zeta and CD3-epsilon, and characterized the developmental and functional consequences of these alterations on TCR signaling. The results of these studies demonstrated that TCR-ITAMs are functionally analogous but act in concert to amplify TCR signals. TCR signal amplification was found to be critical for thymocyte selection, the process by which potentially useful immature T cells are instructed to survive and differentiate further-(positive selection), and potentially auto-reactive cells that may cause auto-immune disease are deleted in the thymus (negative selection). In current studies we are using conditional gene expression systems to analyze the importance of TCR signaling at specific stages of development. Signaling molecules that function downstream of the TCR or that function to 'fine-tune' the TCR signal. Our results with TCR-ITAM mutant mice suggested that other signaling molecules can compensate for the reduction in TCR signal strength. An initial FACS-based search for candidate compensatory molecules led us to CD5, a TCR associated trans-membrane protein that inhibits TCR signaling. Importantly, we found that CD5 surface expression is regulated by and parallels TCR signal intensity. Thus, rather than simply functioning as a static inhibitory co-receptor, CD5 regulation by TCR signaling provides a feedback mechanism to 'fine-tune' the overall TCR signaling response during thymocyte selection since the expression of CD5 depends upon the intensity of TCR signaling. An obvious benefit of such fine-tuning of the TCR signaling response would be to enable the generation of a T cell repertoire with the maximum possible diversity since it would allow a broader range of TCRs to pass through the signaling threshold 'window' of positive selection. Since little is known about how CD5 regulates TCR signaling, we initiated a project to characterize CD5 function, both genetically and biochemically. We have also begun a search for additional tuning molecules using a microarray based screen. The identification of such molecules may be relevant to the diagnosis and treatment of human autoimmune diseases since these molecules function to determine the activation threshold for T cells. Identification of new genes that regulate T cell development. We identified a novel T-lineage restricted protein, designated Themis. Biochemical studies indicate that Themis functions in the TCR signaling pathway and may have an important role is helping to sustain TCR signaling. Themis-/- and conditional Themis deficient mice have been generated and their phenotype reveals an important role for this protein in late thymocyte development and selection. Themis contains a novel (CABIT) domain of unknown function. Current and projected experiments are directed at elucidating the mechanism by which Themis regulatesT cell signaling and determining the function of the CABIT domain. We also identified several other genes that are highly expressed in developing T cells (thymocytes) but have not yet been characterized. We are currently generating mice with targeted mutations of these genes to study their role in lymphopoiesis. Genes controlling Hematopoietic Stem (HSC) cell maintenance and self-renewal. The hematopoietic system is composed of a functionally diverse group of cells that originate from a common hematopoietic stem cell (HSC) capable of long-term self-renewal and multi-lineage differentiation. Self-renewal ensures that a pool of HSCs persists throughout life, whereas differentiation leads to the continuous generation of all circulating blood cells including lymphocytes, myeloid cells, erythrocytes and platelets. Several years ago we initiated experiments aimed at identifying genes important for HSC generation and maintenance. Our initial studies focused on the role of LIM domain binding protein-1 (Ldb1) in hematopoiesis as prior work had suggested a function for Ldb1 in the hematopoietic system. The results of these experiments revealed a critical function for Ldb1 in regulating the self-renewal/differentiation cell fate decision in hematopoietic stem cells and suggest that Ldb1-nucleated multi-subunit transcription complexes may control maintenance of lineage specific stem cells. Consistent with this, a genome-wide ChIP-seq screen identified Ldb1-complex binding sites within the promoter/gene body of a high percentage of genes known to be essential for HSC maintenance. These binding sites were frequently co-occupied by the transcription factors Tal1 (Scl) and Gata2, two proteins known to be essential for HSC maintenance. Strong co-occupancy of the same sites by Ldb1 Tal1 and Gata2 indicates that multimeric complexes that include these proteins as subunits are important for regulating the expression of maintenance-critical genes in HSCs. Deletion of Ldb1 in HSCs resulted in loss of HSCs suggesting that Ldb1 complexes function as 'master regulators' of the transcriptional program regulating HSC maintenance/self-renewal. Current studies are focused on exploring the potential role of Ldb1 complexes in the maintenance of hematopoietic tumor stem cells particularly those that predispose to T-Cell Acute Lymphoblastic Leukemia (T-ALL). Identification of Ldb1 protein complexes as master regulators of erythropoiesis Our recent studies on Ldb1 deficient mice identified a critical role for this protein in both fetal and adult erythropoiesis. Ldb1 is a subunit of a multimeric protein complex in erythroid progenitor cells that includes the adapter protein Lmo2 and the transcription factors Scl (Tal1) and Gata1 (as opposed to Gata2 which is a subunit of Ldb1 complexes in HSCs). Gata1 had been shown previously to have an essential function in the regulation of virtually all known erythroid genes. Our results from ChIP-seq and microarray experiments where Ldb1 expression was reduced in murine erythroleukemia cells using shRNA demonstrate that Ldb1/Tal1/Gata1 complexes bind at promoters and regulatory sites within nearly all erythroid genes known to be controlled by Gata1 and Tal1. Taken together, these findings demonstrate that Gata1 and Tal1 function primarily through Ldb1 complexes to globally activate erythroid gene expression